Fast and Flexible Conjunction Coding in Biological and Artificial Vision

Project Summary
How does the human brain encode visual feature conjunctions? Two inﬂuential, yet disparate, research traditions
have proposed two different mechanisms. Research in neurophysiology and computer vision has explored static
conjunction coding, where feature conjunctions are automatically extracted via a feedforward hierarchy. While
efﬁcient, this mechanism may be limited to encoding conjunctions enabled by the hierarchy's learned connectivity.
By contrast, research in cognitive psychology has explored dynamic conjunction coding, which sequentially
encodes task-relevant conjunctions via attentional selection. While slow, this mechanism is ﬂexible and capable
of encoding any feature conjunction. Despite evidence for both mechanisms, their interplay remains unclear. In
this project, we leverage advances in deep learning and open neuroimaging datasets to understand how these
two mechanisms interact in the human brain, yielding the best of both worlds: fast, but ﬂexible conjunction coding.
Through the three complementary Speciﬁc Aims, we advance our understanding of these fundamental issues in
vision science, and on a practical level, develop approaches that can be used to improve computer vision, aiding
the development of useful technologies like autonomous vehicles. In the course of this project, I will master
modern approaches in deep learning and computational neuroscience through the mentorship of my sponsor Dr.
Kriegeskorte and my co-sponsor Dr. Fusi, equipping me for a career leading a lab that bridges cognitive science,
neuroscience, and artiﬁcial intelligence.
Hypotheses: The human brain implements static conjunction coding via neural populations with “and-like” tuning
to feature combinations that emerges via feedforward convergence of neurons tuned to single features, while dy-
namic conjunction coding requires recurrent connections. Static conjunction coding can rapidly encode familiar,
but not unfamiliar conjunctions, while dynamic conjunction coding can encode any conjunction, but more slowly.
Aim 1: We use a massive open-source fMRI dataset to chart the prevalence of static conjunction coding through-
out the human visual system, using a method we developed in preliminary analyses.
Aim 2: We apply “synthetic neurophysiology” to feedforward artiﬁcial neural networks to understand how static
conjunction coding emerges in a feedforward hierarchy, beginning by characterizing conjunction-tuned units iden-
tiﬁed in preliminary analyses, followed by testing inﬂuential models for how this occurs in biological vision.
Aim 3: We test whether feedforward artiﬁcial neural networks exhibit similar limitations on a visual search task
compared to known results for human feedforward vision, followed by testing whether introducing recurrent con-
nections to networks can overcome these limitations.

Public health relevance
Project Narrative The human visual system has the remarkable ability to quickly and ﬂexibly combine visual features, like shape and color, into the coherent objects that we perceive, enabling effective interaction with the world. In this project, we use state-of-the-art techniques in deep learning and neuroimaging to synthesize two inﬂuential theories for how the visual system accomplishes this feat. Understanding this fundamental visual operation will both en- able implementing it in useful machines, like self-driving cars, to improve public safety and industrial efﬁciency, and help develop treatments for patients with neurological deﬁcits in combining visual features (such as Balint's syndrome or visual agnosia).